IMAGING TECHNOLOGY DEVELOPMENT FOR INOVATING OLYMPUS MICROSCOPE SYSTEM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Learning RICS and related methods for developing the microscope system. Also we would like to discuss a theory of these imaging technologies.